The interface of neurons and cancer

Project Summary
The F99 portion of this proposal investigates the role of the brain enriched E3 ubiquitin ligase TRIM9 in melanoma
progression. The K00 portion of this proposal investigates the interface of tumors and neurons, and how this
interface influences cancer progression. Tumors are composed of multiple cell types and heterogenous cancer
cells. Cellular heterogeneity may be attributed to the dedifferentiation of cancerous cells, where characteristics of
their differentiated states are lost, and new ones acquired. Melanoma, a cancer of melanocytes, cells derived from
the neural crest, has been suggested to have undergone dedifferentiation. Interestingly, the brain-enriched E3
ubiquitin ligase TRIM9 is highly expressed in aggressive melanoma patient samples and multiple melanoma cell
lines. Intriguingly, neurons, which also express TRIM9, are also derived from the neural crest. The Gupton lab
identified TRIM9 as a potent regulator of exocytosis, actin dynamics, and directed axon navigation in developing
neurons. The lab found that TRIM9 negatively regulates the actin polymerase VASP via non-degradative
ubiquitination and negatively regulates exocytosis by preventing SNARE complex formation. My preliminary data
suggest that TRIM9 modulates focal adhesion morphology and number, cell size, random migration, directed
migration in response to extracellular stiffness, proliferation, and protease secretion in melanoma. In addition,
preliminary TRIM9 immunoprecipitation mass spectrometry experiments identified several potential protein
interactors that regulate focal adhesion dynamics, cell cycle progression, and trafficking in melanoma. The goal
of this predoctoral training proposal is to define the role of TRIM9 in focal adhesion dynamics, migration, and
exocytosis in vitro and tumor growth and metastasis in vivo in melanoma. I will use a combination of cell and
molecular biology techniques, biochemistry, microscopy, and a mouse model of melanoma. The interaction
between cancerous cells and other cells in the tumor microenvironment has been suggested to influence tumor
progression. In patients, innervated tumors are correlated with morbidity. In addition, neuronal activity in small cell
lung cancer tumors increases proliferation and metastasis in mice. Although progress has been made in
delineating the mechanisms that underly cancer- nerve interactions resulting in increased tumorigenesis and poor
prognosis, there is much yet to understand. The postdoctoral training proposal aims to identify mechanisms by
which the reciprocal interactions between neurons and cancer cells increase tumor progression. To identify
mechanisms, I will use cellular and molecular biology techniques, biochemistry, and MS assays, gained in the
F99 phase, in combination with neuroscience techniques, which I will gain in the K00 phase. Together, the
predoctoral and postdoctoral work aim to answer how cellular phenotypes and cancer progression are affected
by either gaining the expression of a brain- enriched E3 ubiquitin ligase or interactions between neurons and
cancerous cells in the tumor microenvironment.

Public health relevance
Project Narrative Cancer heterogeneity, the influence of the tumor microenvironment, and the mechanisms which contribute to tumor dissemination and morbidity remain to be elucidated. Defining and understanding these mechanisms will facilitate cancer therapies and patient outcomes. This training proposal aims to clarify the roles of the brain- enriched E3 ubiquitin ligase TRIM9 in melanoma and define pathways in the interactions between neurons and cancer that influence tumor progression.